FRONTIERS: Foreign-Born Latinos Cancer Screening

Project Summary
Latino immigrants experience numerous disparities in the receipt of routine health care. They may be at
risk for significant poor outcomes from cancer; however, the extent to which Latino immigrants experience
appropriate cancer screening and prevention services, compared with US born-Latinos and non-Hispanic
whites, is not well understood. This may be, in part, because studying the health care of Latino immigrants has
numerous challenges. Foreign-born status is not widely and routinely collected, and foreign-born patients may
not have the access to healthcare related datasets that would objectively record their healthcare utilization.
Additionally, while there is some scientific evidence that different sub groups of immigrants (Mexican
individuals, for instance, Spanish speaking individuals, rural- residing immigrants) may utilize services
differently in general than contrasting groups, the knowledge on these differences is incomplete because
studies to date have failed to include all necessary data to understand these relationships.
In order to better understand cancer prevention disparities between foreign-born Latinos, US-born
Latinos, and non-Hispanic Whites, we will leverage a unique data resource from a large, national network of
community health centers with shared electronic health record data that is linked to community-level social
determinants of health data. This large, longitudinal dataset contains country of birth for >100,000 Latinos and
also contains unprecedented data linkages which will let us assess disparities and better understand which
specific groups are most at risk for the under-utilization of cancer prevention. Understanding these factors that
most heavily impact cancer preventive service use is crucial to the prioritization of population-based
interventions to improve cancer outcomes.
This research will enable action/intervention in three ways: 1. It will help clinical providers understand
their patients' barriers to care utilization, and further point-of-care efforts to address these barriers that
influence their Latino immigrant patients' utilization of recommended cancer prevention services. 2. It will
facilitate strategic partnerships between healthcare providers and community agencies poised to intervene in
social factors in the lives of Latino immigrants. 3. It will enable more informed policy decisions to improve
public health and wellness in foreign born Latinos.

Public health relevance
Project Narrative Foreign-born Latinos in the United States are at risk for poor health outcomes, including poor outcomes for cancer. It is uncertain whether or not they receive fewer prevention services for cancer, and if so, which specific factors may be most responsible for the lower receipt of these services. This project will use a highly innovative electronic health record database that contains country of birth information and is linked to community information in order provide policy makers and healthcare providers better information about what cancer prevention services their patients or community members are most at risk for underutilizing.